Elucidating the Roles of the Membrane-Binding Proteins ciBAR1 and ciBAR2 in Ciliogenesis

PROJECT SUMMARY
Airway motile cilia play an important role in mucociliary clearance, the primary innate defense mechanism of
the lung, by propelling inhaled pathogens trapped in mucus up and out of the respiratory tract. Impaired ciliary
function is commonly found in patients with chronic pulmonary diseases, and genetic mutations that result in
aberrant cilia formation and loss of function often lead to the development of genetically heterogenous,
multisystem disorders called ciliopathies. The current body of literature suggests that the unique composition
and morphology of the ciliary membrane that envelopes the cilium are involved in maintaining cilia function and
homeostasis. However, the molecular players and mechanisms underlying the formation and maintenance of
the ciliary membrane remain poorly understood. The overarching objective of this proposal is to define the
physiological roles of the membrane-binding proteins ciBAR1 and 2 (formerly known as FAM92A and B) in
ciliogenesis and airway ciliated cell differentiation by using novel knockout mouse models. Both ciBAR proteins
possess a single Bin/Amphiphysin/Rvs (BAR) domain, which allows them to dimerize and form crescent-
shaped structures to preferentially sense and sculpt curved membranes. Previous studies have shown that
ciBAR1 and 2 bind to the ciliary protein Chibby1 (Cby1), which acts in preciliary vesicle recruitment and basal
body docking during early stages of ciliated cell differentiation. ciBAR 1 and 2 colocalize with Cby1 at the ciliary
base and play crucial roles in ciliogenesis, but their in vivo functions are currently unknown. The central
hypothesis of this proposal is that ciBAR1 and 2 play key roles in ciliogenesis and differentiation of
airway ciliated cells via their membrane-binding and shaping activity. To address this hypothesis, I will
use novel ciBAR1-/- and ciBAR2-/- knockout mouse models developed by our laboratory and propose the
following Specific Aims. In Aim 1, I will investigate if the loss of ciBAR1 or ciBAR2 in mice results in ciliary
defects in the trachea. In Aim 2, I will examine the roles of ciBAR proteins in formation and maintenance of
ciliary membranes during ciliogenesis using primary cell cultures, biochemical methods, and cell biological
approaches. Collectively, my proposed project will shed light on the in vivo functions of ciBAR1 and 2 in
ciliogenesis and airway ciliated cell differentiation and advance our existing knowledge of how the ciliary
membrane is generated and maintained throughout the process of ciliogenesis.

Public health relevance
PROJECT NARRATIVE Dysfunctions in airway motile cilia, hair-like organelles that line the respiratory tract, are implicated in pulmonary disorders such as SARS-CoV2 infection, as well as ciliopathies that have devastating effects on multiple organ systems; however, although cilia play an integral role in airway innate immunity, the biological processes underlying the formation and maintenance of these organelles are still poorly understood. While the unique shape and lipid composition of the ciliary membrane is thought to contribute to cilium homeostasis, it is still unclear how the ciliary membrane is assembled and maintained during and after cilia formation. My research will provide new insight into the mechanisms that drive ciliary membrane shaping and maintenance by investigating the roles of the membrane-binding ciBAR proteins in ciliogenesis and airway ciliated cell differentiation, thus furthering our current understanding of the biology of cilia and ciliopathies.